An exploratory sequential mixed methods study on pregnancy loss care

Project Summary:
Since the Dobbs v. Jackson Women’s Health Organization Supreme Court decision in June 2022, multiple
states have implemented abortion bans. While not the intended target of abortion restrictions, care for
pregnancy loss often overlaps with abortion care and can be affected by abortion policy. Given the dynamic
ongoing state policy changes, the lack of baseline monitoring of pregnancy loss and treatment trends, and the
known socioeconomic and racial variation in pregnancy loss care, it is imperative to document clinician and
patient experiences of navigating pregnancy loss care and to develop data collection systems that can be used
to monitor changes in practices and outcomes over time. The goals of the proposed study are to assess: 1) the
extent to which pregnancy loss management practices are influenced by newly-enacted policies related to the
Dobbs ruling; 2) the implications of these new policies and practice changes for patient-centered quality care;
and 3) which institutional factors may be influential in supporting patient-centered care despite restrictions. We
will conduct an exploratory sequential mixed methods study with the following three aims: AIM 1 – Characterize
clinician attitudes, knowledge, and decision-making related to clinical management protocols for pregnancy
loss in states with new abortion restrictions following the Dobbs decision. Using a combination of rapid
qualitative analysis (RQA) and traditional thematic qualitative methods, we will conduct in-depth interviews with
diverse clinicians (n=30-40) providing pregnancy loss care, recruiting across practice settings and state
abortion policy. In this analysis we will document real-time decision-making and understand practice changes
and the barriers to and facilitators of evidence-based patient-centered care. AIM 2 – Document patient
experiences with pregnancy loss management practices in states with and without new abortion restrictions
following the Dobbs decision. We will conduct in-depth qualitative interviews with patients (n=40-50)
experiencing pregnancy loss, with representation across first and second trimester, state abortion policy, and
demographic characteristics. Using a similar approach to Aim 1, we will explore patient understanding and
effects of policy changes and the barriers and facilitators of high-quality care. AIM 3 – Monitor and evaluate the
impact of restrictive abortion policies implemented post-Dobbs on first and second trimester pregnancy loss
management practices using EPIC and EPIC Cosmos electronic medical record data. We will first develop and
internally-validate a set of search filters to identify pregnancy losses, treatments, complications, and delays in
care (Aim 3a).We will then validate filters externally at other institutions to confirm fidelity (Aim 3b), and then
will use filters to collect data at four case study institutions in most and least restrictive policy environments to
assess changes in care related to state policy using a differences-in-differences analysis, and assess impact
on disparities in care using a triple-differences analysis (Aim 3c). We will then apply filters to aggregate data in
EPIC Cosmos to assess national trends and the impact of the Dobbs decision nationwide (Aim 3d).

Public health relevance
Project Narrative: The proposed study will rigorously measure and assess the consequences of state abortion restrictions on pregnancy loss management practices and outcomes, to understand the impact of abortion restrictions on other pregnancy care and to evaluate the effect on existing racial and socio-economic care disparities. This study will also provide new tools for improved surveillance of pregnancy loss and management practices. Findings from this study will fill knowledge gaps and provide critical insights that may guide future organizational and state policy.